Transcriptional Regulation of Mammalian Hepatic Development

DESCRIPTION (provided by applicant): The liver is the largest glandular organ in the body and is responsible for diverse functions including regulation of glucose and lipid metabolism, generation of bile, and detoxification of ingested substances. The primary cell type that is responsible for these functions is the hepatocyte. However, in order to generate a working liver the hepatocyes must function as part of community of liver cells. For these cells to properly interact they must be arranged in a specific format that produces the discreet of architecture of the liver that is so crucial for normal hepatic activity. Indeed, when the architecture of the liver is disrupted the liver cannot function resulting in hepatic failure. Hepatic architecture is produced during embryonic development when individual liver cells are generated and organized to produce tissues. The aim of this proposal is to define the basic molecular processes that control development of the liver as an organ. This will be achieved by studying mouse embryos and cells that lack a specific transcription factor, HNF4a that is required for expression of over 600 hepatic genes. HNF4a is also an essential regulator of the epithelial transformation of the hepatic parenchyma during liver development. We propose that HNF4a regulates liver development by both direct and indirect mechanisms. The first aim will test whether HNF4a controls expression of such a large array of liver genes by regulating expression of a cascade of downstream transcription factors. In the second aim we will test whether HNF4 coordinates expression of genes encoding adhesion and cell junction proteins to elicit the epithelial transformation of the liver. Finally we will test whether it is necessary for hepatic cells to form cell adhesions and junctions in order to control hepatocyte differentiation. Success in the proposed experiments will elucidate the fundamental mechanisms that govern formation of the liver as an organ.